Defining the role of NF1 and SPRED1 loss in melanoma

Project Summary/Abstract
In melanoma, loss of function mutations in NF1 are the third most common oncogenic alteration after activating
mutations in BRAF and NRAS. The RAS GTPase-activating protein NF1 provides negative feedback from the
MAPK pathway to RAS by binding to SPRED1 at the plasma membrane where it is inactivates RAS-GTP. We
discovered recurrent inactivating mutations of SPRED1 in melanoma, occurring in a mutually exclusive pattern
with inactivating NF1 mutations, consistent with their functional overlap. Inactivation of either tumor suppressor
often co-occurs with additional MAPK activating mutations such as activating mutations of KIT. We
hypothesize that NF1 or SPRED1 inactivation may reduce the efficacy of therapeutic inhibition of KIT and
similar gain of function alterations in the MAPK pathway. The objective of this research is to identify the
spectrum of additional MAPK activating alterations that occur in the setting of NF1 or SPRED1 loss and to
determine the role of NF1 or SPRED1 in melanoma progression and response to targeted therapies. Our
central hypothesis is that NF1 or SPRED1 loss increases MAPK signaling but that full malignant transformation
requires additional alterations that feed into the MAPK pathway. We will catalogue the spectrum of cooperators
that form oncogenic pairs with NF1 or SPRED1 inactivation and validate their contributions to tumorigenicity
both in vitro and in vivo. We hypothesize that identifying oncogenic pairs and developing therapeutic strategies
that address both members of a pair will lead to improved outcomes for patients. We have provided proof of
principle for this concept by demonstrating that dual inhibition of KIT and MEK are synergistic for melanomas
with an oncogenic pair consisting of KIT mutation and NF1 or SPRED1 loss. We will also investigate the direct
physical interaction between KIT and SPRED1, including the phosphorylation of SPRED1 by KIT or its
downstream effectors and effects of KIT mutation on SPRED1 binding which may lead to additional avenues
for inhibiting melanomas with KIT or SPRED1 mutations. We have extended this framework for similar studies
for other cooperators of NF1 and SPRED1, such as ERBB2 S310F. We will investigate whether this cooperator
can directly interact with the SPRED1/NF1 complex. This research is significant since it will lead to novel
therapies for a significant number of melanoma patients for whom targeted therapies are not currently
available. The proposed research is innovative because it tests a novel hypothesis why treatment of mutations
such as KIT have limited efficacy in melanoma and dives into direct functional interactions that can be targeted
by new therapies. Shedding light onto the complex signaling pathway perturbations in the considerable share
of melanomas with NF1 or SPRED1 will have a considerable impact for patients with melanomas for which
treatment options are currently limited.

Public health relevance
Project Narrative Affecting up to 10% of the population, melanoma continues to be a deadly form of cancer for many patients despite recent advances in immunotherapies. A group of melanomas that harbor early NF1 or SPRED1 mutations have particularly poor outcomes and developing new therapies will require a more thorough understanding of the affected signaling pathways. At the end of this research, we expect to better understand how the most common cooperator, KIT mutation, regulates SPRED1 phosphorylation and the KIT/SPRED1 interaction and to understand how the KIT/SPRED1/NF1 complex is involved in initiating melanoma in specific cells of origin and identify susceptibilities to intervention.